Administrative Core

The primary goal of the Administrative Core is to enhance the research environment by building on the synergy
among the Project Leaders, Core Director, and Industry Partners and provide integration of the goals of the
program project grant (PPG). The Administrative Core will be responsible for the overall administrative
management of the program, providing data management infrastructure and biostatistics support. The core will
make these services available to all investigators participating in the PPG. Project Leaders, Core Leaders, and
Co-Investigators of the PPG will closely interact with the Administrative Core Director and Program Manager to
provide the infrastructure and resources needed to complete all the goals and objectives of Projects 1-3. The
Administrative Core will facilitate the scientific exchange among investigators by scheduling and coordinating
frequent and regular meetings of the PPG members. Oversight will be provided through these regular meetings
and through meetings with the Scientific Leadership Group. The Administrative Core will provide additional
services to ensure scientific progress at the annual meeting with NIH Program and the Scientific Advisory
Board. The Administrative Core will maintain records and documentation for local and federal requirements,
maintain budgetary oversight for the PPG, assist with progress report submission, coordinate travel and
meetings of advisory committee members, coordinate implementation of INTERACT meeting with the
FDA, and track and coordinate manuscript submissions with all PPG investigators at the primary institution
(UAB) and the sub-contract institutions (University of Oxford and Duke University). The Administrative Core will
establish consistent and high-quality data collection, management, and sharing procedures and will establish
high-quality and state-of-the-art biostatistical analyses that will be applied across all projects and scientific
cores. Specifically, the Administrative Core will provide guidance on the appropriate data standard, format for
data sharing, and public repository(ies) for data sharing. The Core will also advise investigators on rigorous
experimental design and execution (including power analysis to ensure sufficient planning), provide world-class
biostatistical and bioinformatics expertise, and assist in the dissemination of data with presentation/publication
of results to ensure the highest standards of rigor and reproducibility.